Multiscale transcriptional architecture of the human brain

In America, nearly half of individuals will meet diagnostic criteria for a mental disorder at some point in their life.
Although most mental disorders are moderately to highly heritable, their underlying genetic architecture is
complex. This complexity has hindered efforts to identify biomarkers and develop diagnostic tests and therapeutic strategies for patients. Notwithstanding this complexity, it is reasonable to expect that genetic variants
that predispose individuals to mental disorders will alter gene expression in the brain. Many studies have tried
to identify transcriptional phenotypes of mental disorders in postmortem brain samples, but the use of bulk tissue has resulted in variable cellular composition across samples and datasets, obscuring transcriptional phenotypes and their cellular origins. Recent advances in single-cell (SC) and single-nucleus (SN) transcriptional
profiling offer a new approach to this problem, but these techniques also have technical and statistical limitations. As such, there remain critical gaps in our understanding of how risk factors for mental disorders perturb
gene expression in the human brain. A major impediment to identifying such perturbations is the absence of an
analytical framework for predicting gene expression in the human brain regardless of sampling strategy. The
purpose of this application is to test the hypothesis that the covariance structure of neurobiological transcriptomes provides such a framework. In Aim 1, we will assess the concordance of cell-type signatures and transcriptional covariation in bulk and SC/SN gene expression data from human brain samples. In Aim 2, we will
clarify optimal experimental and analytical parameters for identifying reproducible transcriptional signatures of
rare cell types/states in human brain samples. And in Aim 3, we will exploit reproducible transcriptional covariation in bulk and SC/SN gene expression data to identify cellular and molecular phenotypes of mental disorders
and corresponding genetic variants. Collectively, the proposed studies will have a positive impact by promoting
rigor and reproducibility in neurobiological research through meta-analysis and predictive modeling, while simultaneously advancing new strategies for identifying cellular and molecular phenotypes of mental disorders that
can be readily applied to other molecular species and pathological conditions.

Public health relevance
Mental disorders profoundly affect millions of Americans. This project proposes new strategies for identifying reproducible molecular signatures of cell types and biological processes in the human brain. This information is important for understanding how these cell types and biological processes are perturbed in mental disorders.